CoVPN 3008 - Multi-Center, Randomized, Efficacy Study of COVID-19 mRNA Vaccine in Regions with SARS-CoV-2 Variants of Concern

FOA: PA-20-272: Administrative Supplements to Existing NIH Grants and Cooperative Agreements
Activity Code/Award: UM1/A1068614-15 (parent award)
------------------------------------------------------------------------------------
Project Abstract
This proposal outlines the scientific agenda for the COVID-19 Prevention Network (CoVPN) Vaccines Leadership
Operations Center (LOC) for implementation of the COVID-19 vaccine efficacy trial entitled “Multi-Center,
Randomized, Efficacy Study of COVID-19 mRNA Vaccine in Regions with SARS-CoV-2 Variants of Concern.”
With the global COVID-19 pandemic, we recognize a significant need for vaccines that modify COVID-19 in
SARS-CoV-2 infected individuals. Addressing this gap, the National Institutes of Health (NIH) led rapid
constitution of the CoVPN, partnering 5 NIH supported clinical trial networks, to create an enhanced network of
physician-scientists at 145 United States (US) and 71 international clinical trial sites in 17 countries dedicated to
developing globally effective vaccines for SARS-CoV-2. Due to its extensive experience implementing global
HIV vaccine trials over the last 20 years, the HIV Vaccine Trials Network (HVTN) LOC was selected as the LOC
for CoVPN vaccine trials.
This Phase 3, observer-blinded, placebo-controlled, crossover-vaccination study will test the efficacy of the
COVID-19 ancestral strain mRNA vaccine in preventing COVID-19 disease regardless of severity, and
preventing COVID-19 severe disease in people who are at risk for severe COVID-19 in areas of the world where
the prevalence of the SARS-CoV-2 1.351 strain is substantial.
The trial has been designed to provide as rapid assessment of efficacy as possible in regions of the world where
local access to effective vaccines are limited. Subjects will be randomized in a 1:1 ratio to receive immediate or
deferred vaccine. The blinded cross-over is expected to take place when vaccine benefit is declared based on
at least 50 primary COVID-19 endpoints, anticipated to be accrued approximately 3 months post-trial start. All
trial endpoint assays will be done using qualified and validated assays for diagnosis and immune monitoring.
Specific aims of this study are to demonstrate efficacy of COVID-19 mRNA (Moderna mRNA-1273) vaccine to
prevent virologically-confirmed symptomatic COVID-19 starting 14 days after dose 2 in adults who are at risk of
severe COVID-19; to assess vaccine efficacy of COVID-19 mRNA vaccine to prevent severe COVID-19 starting
14 days after dose 2 in adults who are at risk of severe COVID-19; and to assess safety and tolerability of
COVID-19 mRNA vaccine in adults who are at risk of severe COVID-19.
This efficacy trial will tell us much about ability of an mRNA vaccine against the ancestral Wuhan strain of SARS-
CoV-2 to protect individuals exposed to divergent strains, and in particular 1.351 first predominant in South
Africa. In addition, it will improve our understanding of the dynamics and duration of these immune responses
and will inform rational design and testing of preventive and therapeutic monoclonal antibody interventions in
parts of the world where alternative strains continue to proliferate. Lastly, the results of this trial will be used to
assess registration of this vaccine product as well as to modify future COVID-19 vaccine trials planned over the
next 12 months.

Public health relevance
Project Narrative The outbreak of SARS-CoV-2 across the globe presents an unprecedented health risk to the world's population and requires intensive study of key gaps in our understanding of the immune response and what adaptations lead to protective immunity. In this study, the CoVPN will apply its world class laboratory, biostatistical and vaccine trial leadership expertise to assess this response in 14,000 persons at clinical trial sites in 8 countries in Sub-Saharan Africa. The goal of this protocol is to rapidly assess the efficacy of COVID-19 mRNA (Moderna mRNA-1273) vaccine, to safely prevent symptomatic and severe COVID-19 disease in adult individuals exposed to SARS-CoV-2 South African variant B.1.351 and other circulating variants of concern. Title